CORE A: Administrative Core

PROJECT/CORE: Administrative Core A Project/Core Leader Name: John Q. Trojanowski, MD, PhD Project Summary/Abstract Core A, the Administrative Core of this NINDS Morris K. Udall Parkinson's Disease Research Center of Excellence (Udall Center) at the University of Pennsylvania (Penn) Perelman School of Medicine (PSOM), will facilitate accomplishing the goals of this multidisciplinary research program. Briefly, the goals of this Center are to elucidate mechanisms of progressive neurodegeneration in Parkinson's disease (PD), especially those that underlie cognitive impairments in PD without and with dementia (PDD) and in dementia with Lewy bodies (LBs) or DLB (Projects I/II) that we refer to collectively as LB disorders or LBD. Udall Center investigators hypothesize that LBD lead to neuron dysfunction and death resulting from the differential transmission of pathologic alpha-synuclein (a-syn) strains and their neurotoxic effects in patients with LBD. Thus, Projects III/IV seek to elucidate the strains underlying PD, PDD and DLB compared to those underlying multiple system atrophy (MSA) characterized by glial inclusions formed by misfolded a-syn. Accordingly, the Aims of Core A are to: oversee budgetary and fiscal aspects of this Udall Center; promote/foster interactions between Cores and Projects, as well as interactions of Penn Udall investigators with scientists outside the Center at and beyond Penn; serve as an information resource for the patient community and general public regarding LBD and MSA; monitor the progress of the Cores and Projects; facilitate the sharing of data, reagents, and resources generated by the Penn Udall Center with other researchers in accordance with NIH policies; participate in annual Udall Center meetings to accelerate the pace of advances in understanding synucleinopathies; train the next generation of investigators in this field. In this manner, Core A plays a key role in this Udall Center to foster accomplishment of its mission.